Characterization of tumor-specific human endogenous retroviruses in clear cell Renal Cell Carcinoma

PROJECT SUMMARY / ABSTRACT
Human endogenous retroviruses (HERVs) comprise roughly 8% of our genome. Originally considered “junk
DNA”, we now know that HERVs play diverse roles relating to human health, innate immunity, and cancer.
Repetitive elements have been notoriously difficult to study and quantify due to their repetitive nature and the
lack of a standardized database. In this project, I will leverage a comprehensive database of HERV loci
(HERVdb) created in the Blanco-Melo Lab to accurately measure the expression of HERVs and investigate
their role in clear cell renal cell carcinoma (ccRCC), a common and aggressive form of kidney cancer that
accounts for 80% of renal cancer cases. HERV expression in ccRCC has been linked to tumor immunogenicity
and response to immunotherapy, making it a promising area of research.
Our hypothesis is that HERVs are abnormally transcriptionally activated in tumor cells, where they are
recognized by the immune system due to absence of expression in normal cells; HERV products (RNA or
protein) can thus prime the anti-tumor immune response, resulting in a HERV specific immune response. To
test this, I will pursue two main aims: Aim 1: Define the unique signature of HERVs in ccRCC (clear cell Renal
Cell Carcinoma). Aim 2: Explore the role of HERV-derived tumor-associated antigens across ccRCC samples.
The goal is to establish a clear baseline of HERV expression in ccRCC, identify tumor-specific HERVs, and
explore relevant HERV-derived peptides that could serve as potential therapeutic targets. Ultimately, this
project aims to demonstrate that HERVdb can be used to identify HERVs as targets for ccRCC treatments, and
to establish a reproducible workflow for the interrogation of HERVs in other cancers.

Public health relevance
PROJECT NARRATIVE Despite frequent reports that human endogenous retroviruses (HERVs) are up regulated in clear cell Renal Cell Carcinoma (ccRCC), their precise role in cancer development, progression, and treatment has not been thoroughly investigated. Understanding the relationship between HERV expression in tumors and anti-tumor adaptive immune responses could yield important insights on the design or enhancement of immunotherapies. This project seeks to characterize HERV expression in ccRCC to identify potential tumor-specific antigens and evaluate their immunogenic properties, with the aim of discovering novel therapeutic targets for ccRCC and advancing HERV research in other cancers.